INFRASTRUCTURE DEVELOPMENT FOR HIV CLINICAL RESEARCH

RCMI funding has made possible the development of a solid infrastructure for Phase II/Phase III clinical trials in human immunodeficiency virrts (HIV-1) research. The clinical research program m retrovirolbgy now aims to broaden this infrastructure to include the ability to do more pathogenesis-related, late Phase Yearly Phase ll trials, as well as trials in "specialty" areas of HIV-l research, such as HIV-1-associated malignancies and neurologic diseases. To accomplish this goal, an HIV-l clinical research structure capable of implementing such studies must be developed. The specific aims are to: l. Expand the research scope of the clinical program in retrovirology i) Develop clinical research expertise in later Phase I and earlier Phase II trials focusing more on HIV- l pathogenesis-related questions. ii) Broaden the spectrum and scope of HIV-1 clinical, research to include "specialty" research in HIV-l-associated diseases, including HIV-1 associated oricologic, neurologic and ophthalmologic research. 2. Improve the infrastructure of the Hawaii AIDS Clinical Research Program (HACRP)to successfully implement pathogenesis-related studies. 3. Develop a "critical mass" of investigators with selective expertise in HIV-1-related specialty fields.